Effect of intranasal HB-EGF treatment on brain glucose metabolism and inflammation after TBI in the developing brain

Pediatric traumatic brain injury (TBI) is the leading cause of significant life-long cognitive and sensorimotor
disabilities. To date, acute care is limited to supportive measures, and there continues to be a lack of targeted
therapeutics to improve neurologic outcome. Metabolic crisis from impaired oxidative glucose metabolism and
inflammation are the hallmarks of TBI. The dysregulation and impaired mitochondrial function results in the
depletion of energy in the form of ATP. Simultaneously, TBI is characterized by activation of microglia – the
resident macrophages of the brain – to clear damaged tissue. The ongoing secondary injury due to mitochondrial
dysfunction and decreased cell viability signal the microglia to remain in a persistently activated state, becoming
dysregulated and further propagating the inflammatory cascade. Targeted therapy that improves oxidative
glucose metabolism and limits inflammation is crucial. Recent data from our lab found that a neurotrophic growth
factor, heparin-binding epidermal growth factor (HB-EGF) increases pathways responsible for oxidative
phosphorylation and decreases inflammation. Our preliminary experiments suggest that intranasal HB-EGF
quickly enters the brain and improves mitochondrial health. Therefore, we hypothesize that treatment with
intranasal HB-EGF after moderate-severe pediatric TBI will improve brain oxidative glucose metabolism and
mitochondrial function while decreasing inflammation. In the first aim, we will determine whether treatment with
intranasal HB-EGF after TBI improves brain oxidative glucose metabolism and delineate the regional and
temporal effects of intranasal HB-EGF after developmental TBI. In the second aim, we will determine whether
treatment with intranasal HB-EGF in the acute period after TBI decreases inflammation. The impact of this project
is that we will gain a greater understanding of the regulation of metabolism and inflammation from treatment with
HB-EGF in normal and injured developing brain.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) in children causes life-long impairments because the injury is superimposed during a time of rapid brain growth and development. In this study, we will test whether heparin-binding epidermal growth factor administered intranasally can attenuate injury by decreasing inflammation and improving brain metabolism. The proposed research is relevant to public health because it will help test whether a novel and clinically relevant therapeutic approach can decrease long-term neurological sequelae in pediatric TBI.